Center for Cellular Metabolism Research in Oklahoma

PROJECT SUMMARY/ABSTRACT
The proposed studies will be done under the auspices of the parent COBRE award (P20GM139763). The goal
of the parent award is to support research project leaders (RPL) to scientific independence in areas of cellular
metabolism by creating and unifying resources under the Center of Cellular Metabolism Research in Oklahoma
(CMRO).
A multitude of complications can arise from type 1 (T1D) and type 2 (T2D) diabetes, which leads to a major
burden on the healthcare system as medical care costs soar from these conditions. One of these complications
occurring among patients with diabetes is non-alcoholic fatty liver disease (NAFLD) that can cause serious liver
damage. NAFLD is a spectrum that ranges from isolated, relatively benign steatosis (NAFL) to the more harmful
non-alcoholic steatohepatitis (NASH) associated with liver fibrosis. This liver damage pathogenesis involves a
variety of cell types: in general NAFLD, but especially NASH, is hallmarked by chronic inflammation and
heightened immune cell activity, which can activate hepatic stellate cells and endothelial cells, thereby resulting
in a self-perpetuating pro-inflammatory and pro-fibrogenic network that can eventually progress into liver
cirrhosis. However, the exact cellular contributions, and how these cells orchestrate the propagation of liver
damage are not known, as previous studies mainly focused on the role of individual cell types rather than their
interactions. To fully elucidate disease pathogenesis, it will be important to gain molecular insights into the
reciprocal interactions between the main cell types that drive NAFLD progression, especially since the
pathophysiological complexity of NAFLD has represented a challenge in the development of potential therapeutic
targets, and there are currently no specific pharmacological treatments for NAFLD and/or NASH. Therefore, our
proposal will address these knowledge gaps with regard to the basic mechanisms that promote diabetes-induced
chronic liver disease in an in vivo setting. Herein, we will focus on examining the cell type-specific changes
underlying T1D- and T2D-induced NAFLD/NASH in a cell-dependent manner. The combined expertise of Drs.
Cleuren (endothelial cells), Gorman (immune cells), and Stout (hepatic stellate cells) is unique to this application,
as this forms a highly synergistic approach to study diabetes-induced NAFLD pathogenesis. Elucidating not only
the cell-specific molecular changes but particularly the cellular interactions, which would be lost if individual labs
would only focus on their respective cell type of interest, is likely to uncover novel mechanisms that may lead to
more effective therapies for NAFLD/NASH. Successful completion of this proposal will elucidate cell-specific
differences underlying diabetes-associated complications.

Public health relevance
PROJECT NARRATIVE Type 1 (T1D) and Type 2 (T2D) diabetes are associated with serious health complications, one of which is non- alcoholic fatty liver disease (NAFLD) where hepatic stellate cells, endothelial, and immune cells interact and cause a self-perpetuating pro-inflammatory and pro-fibrogenic network that can eventually progress into liver cirrhosis. However, the true extent of the cell-specific contributions, and how these cells orchestrate the propagation of liver damage are not known, as previous studies mainly focused on the role of individual cell types rather than their interactions. Therefore, given the PI’s combined expertise on different cell types and experimental approaches, our research will focus on examining the cell type-specific changes underlying T1D- and T2D-induced NAFLD in an in vivo setting, which is expected to uncover novel mechanisms that may lead to more effective therapies for NAFLD.